OTHER FUNCTIONS: QUANTIFICATION OF BEHAVIORAL AND PHYSIOLOGICAL EFFECTS OF DRUGS

The goal of this project is to develop a mobile, smartphone/tablet-based neurocognitive assessment that will provide a multifactoral (i.e., neural, physiological, performance) evaluation of cognitive functioning associated with impaired driving due to stimulant or depressant usage. The Mobile Alertness and Memory Profiler (M-AMP) will function as an essential tool for worldwide facilitation of epidemiological, comparative studies of drugged driving.